TRIAL OF 4 TREATMENT REGIMENS IN PTS WITH PRIMARY SCLEROSING CHOLANGITIS

Primary sclerosing cholangitis (PSC) is a chronic progressive liver disease that is characterized by ongoing inflammation and destruction of intrahepatic and extrhepatic bile ducts. Primary sclerosing cholangitis generally affects middle aged men and is the fourth leading indication for liver transplantion in adults in the United States. In this pilot trial, the efficacy of four different treatment regimen will be prospectively studied: a. ursodiol alone; b. ursodiol and rotating oral antibiotion; c. ursodiol and low-dose methotrexate; d. ursodiol, low-dose oral methotrexate, and rotating oral antibiotic in patients with PSC. The course and the treatment of PSC will be studed over a duration of 4 years. Specific Aims: The primary aim of this project is to determine if any of the above treatment regimen will slow the disease progression of PSC. The primary endpoint of the study will be treatment failure. In addtiion to evaluating the treatment efficacy, the clinical course of PSC will be studied.